Binational Early Asthma & Microbiome Study (BEAMS)

BEAMS ABSTRACT: Overall
Prevalence of childhood asthma has significantly increased in the last decades, and one potential explanation
for this upsurge is decreased exposure to protective environmental microbes due to improvements in sanitation
and use/overuse of antimicrobial products during pregnancy and early life. In support of this contention, several
studies in isolated rural communities have reported lower prevalence of asthma among children of animal
farmers more heavily exposed to environmental microbes than among their non-farmer peers. If these
observations are applicable to more mainstream US populations is unknown. We recently observed that Mexican
American children living in Tucson, Arizona have a prevalence of childhood asthma that is fourfold higher than
in Nogales, Mexico. This dramatic difference in rates of asthma suggests that, even in this limited geographic
region and among an ancestrally similar population, differential exposures may exist which account for relative
protection against asthma in Mexico. Tucson is only 70 miles north of Nogales, Mexico, which is a 200k inhabitant
city located just south of the US-Mexico border. Nogales, Mexico lacks public sanitation facilities and poverty
rates are very high. In preliminary data, we observed marked differences in microbial communities present in
dust, drinking water, and in stools of one-month-old children between the two cities. Based on these findings,
we propose the Binational Early Asthma and Microbiome Study (BEAMS). The BEAMS overall goals are: to
identify divergent early-life microbial and immune developmental trajectories associated with asthma protection
in Nogales, Mexico compared with Tucson, Arizona, and the environmental factors that promote them; to isolate
the specific microbes, genes and their products that confer such protection; and to ascertain the mechanisms by
which these microbial communities or their products promote asthma protection. To accomplish these goals,
BEAMS will have three Projects and four Cores. We will enroll 250 pregnant mother/offspring dyads of Mexican
ancestry in each city. We will thoroughly assess environmental microbial exposure, maternal gut microbiota and
microbial gene expression, maternal immune markers and meconium microbiome. We will relate these
characteristics to child’s fecal microbiome and metabolome in early life, to asthma-related immune markers in
the child’s blood, as assessed by mass cytometry analysis and single cell epigenetic and gene expression
studies, and to asthma-related clinical phenotypes by age 2 years. We will also assess in mouse models the
specific molecular mechanism that explain the protective effects against the development of childhood asthma
of specific microbial strains and metabolites present in Nogales, Mexico. We expect BEAMS to offer a better
understanding of the early origins of asthma and new asthma prevention strategies applicable to Mexican-
Americans, and potentially to all Americans.

Public health relevance
BEAMS NARRATIVE Childhood asthma leaves millions of children gasping for air and causes over two-hundred thousand hospitalizations each year, but we have no way to prevent it or cure it. In the Binational Early Asthma and Microbiome Study (BEAMS), we will determine which are the environmental microbes and their products present in the border city of Nogales, Mexico, that cause children born there to have four times less asthma than Mexican American children born in Tucson Arizona, just seventy miles north of the border. We will also determine the differences in microbial communities present in stools at both sides of the border, and the immune responses that asthma-protective microbes induce in both young children and mice, with the goal of using all this information to find ways to prevent asthma in the future.